Assessing the impact of water handling practices and seasonality on the effectiveness of a drinking water intervention in Beira, Mozambique

PROJECT SUMMARY/ABSTRACT
Diarrhea caused by enteric pathogens infections is a leading cause of morbidity and mortality for children in
low- and middle-income settings. Upgrading drinking water infrastructure is a common strategy for reducing
enteric pathogen infections, which are predominantly transmitted through environmental media and most of
which lack effective vaccines. However, upgraded water systems alone may not be sufficient to reduce
exposures to enteric pathogens due to the potential for the introduction of contamination from unhygienic
household water handling practices, after water is collected from the source. Seasonal changes in water
availability may also influence waterborne disease transmission pathways, creating another potential barrier to
reducing enteric disease. Here I propose to assess the impact of water handling practices and seasonality on
waterborne transmission of enteric pathogens. I will analyze data from household surveys and microbiological
data from drinking water alongside enteropathogen infection data from an impact evaluation assessing acute
and chronic health outcomes in children up to 12 months of age associated with an upgraded drinking water
system in Beira, Mozambique. A key advantage to the data from the ongoing study is the availability of
microbiological data on infections with specific enteric pathogens, which may provide a more accurate estimate
of health burden compared to reported symptoms alone. In Specific Aim 1, I will assess the impact of water
handling practices, including water storage, household water treatment, and use of alternate water sources, on
enteric pathogen infections in 12-month-old children. In Specific Aim 2, I will assess if and how household water
handling practices interfere with improvements to drinking water source infrastructure using a mediation analysis
framework. Specific Aim 3 will then assess the role of seasonality on differences in enteric health outcomes
and drinking water exposure pathways. Findings from this analysis will provide insight into how behavioral and
seasonal factors impact the relationship between drinking water quality and enteric pathogen infections in a low-
income, urban setting. Understanding these factors will allow for insight into drivers of enteric pathogen
transmission and potential targets for addressing the high burden of enteric disease in settings with limited
infrastructure and vaccine availability.

Public health relevance
PROJECT NARRATIVE Enteric infections, specifically the resulting diarrheal disease, are a leading cause of morbidity and mortality for children under 5 years old in low-income settings. Drinking water contamination, a key source of exposure to enteric pathogens, can be influenced by various household water handling behaviors and seasonal variation in water resources. This project will investigate if and how household water handling practices impact enteric pathogen infection in 12-month-old children in Beira, Mozambique, and the effect of seasonality on these pathways, which will allow for a better understanding of the pathways through which drinking water impacts acute health outcomes.